Ionizable Triazine Lipids for RNA Delivery

PROJECT SUMMARY
There are many potential applications of RNA-based therapies, including silencing gene
expression, gene editing, and developing mRNA vaccines. RNA must get inside cells to serve its
purpose, but its size, charge, immunogenicity, and instability lead to its degradation and do not
allow it to pass through the plasma membrane. One of the most effective ways to protect RNA
and transport it into the cytoplasm is by packaging it in a lipid nanoparticle (LNP). A key
component of LNP formulations is a cationic or ionizable lipid that electrostatically interacts with
the phosphate backbone of RNA and helps to encapsulate it. It also interacts with the cell
membrane and disrupts the endosomal membrane, causing it to rupture and release the RNA into
the cytoplasm. The structure of the cationic or ionizable lipid plays an important role in determining
its ability to form LNPs with RNA and deliver it into cells. Many cationic and ionizable lipids have
been prepared, and with so many potential applications across different diseases, types of RNA,
and cell types, it is important to have a diverse toolbox of lipids available so the optimal formulation
can be developed for each application. The major goal of the proposed work is to develop a library
of triazine-based, ionizable lipids that can be used to form lipid nanoparticles (LNPs) to deliver
RNA into cells. A structure-activity relationship (SAR) correlating lipid structure, LNP physical
properties, RNA delivery in vitro, and cytotoxicity will also be developed and used to guide the
preparation of new lipids. Specifically, modifications to the structures of the amine-based
hydrophilic head groups (Aim 1) and the hydrophobic tails (Aim 2) will be done to determine how
targeted structural changes affect LNP physical properties and in vitro biological activity. The
synthetic approach will make it easy to prepare lipids with symmetrical and unsymmetrical head
groups and tails. Additionally, a protecting group-free synthesis will be developed to streamline
lipid library preparation (Aim 3). Successful completion of these aims will result in a novel class
of triazine-based lipids for RNA delivery and an SAR that will be used to develop more active
lipids.

Public health relevance
PROJECT NARRATIVE RNA-based therapies have the potential to treat a wide variety of diseases that are traditionally considered “undruggable,” but RNA must be stabilized and delivered into cells for it to be effective. The goal of this project is to prepare a library of ionizable, triazine-based lipids that can be used to package, protect, and deliver RNA into cells, and to understand how their structures affect their activities. Ultimately, a new class of lipids will be developed to increase the therapeutic potential of RNA.